Point-of-Care Electrochemical Aptasensor for Long-Term Pharmacological Adherence Monitoring

Point-of-Care HIV Viral Load, Drug Resistance, and Adherence Assays: The long-term goals of this program are to develop novel, low-cost, real-time point-of-care (POC) assays for 1. HIV Viral Load Monitoring; 2. HIV Drug Resistance Monitoring;
and 3. Pharmacological Adherence Monitoring. This contract aims to develop an electrochemical aptamer-based sensor device for simple, rapid, and low-cost detection and quantification of Pre-Exposure Prophylaxis (PrEP) drugs in urine and blood samples at the point-of-care (POC).